SPAD at Midwestern State University

SPAD at Midwestern State University
Project Summary/Abstract
The proposed Midwestern State University (MSU) NIH SPAD proposal addresses the critical need for
increased productivity of sponsored projects administration and enhanced biomedical research and research
training through addressing faculty responsibilities, institutional research culture, and MSU infrastructure. With
SPAD funding, the MSU Office of Sponsored Programs and Research (OSPR) plans to implement policies that
encourage research participation and intra-institutional collaboration such as indirect cost distributions, support
travel to develop collaborations, attend research conferences and national training opportunities, and provide
centralized shared research resources and services. A proposed OSPR Faculty Resource Center (FRC) will
include a collection of grant-related resources to include training webinars/modules (CITI and NCURA) where
faculty could complete training/access, have face-to-face training with colleagues, develop collaborations, and
engage in other capacity-building opportunities. Biomedical research training will be enhanced with SPAD
funding by providing funds to support the research training of administrators and coordinators. The MSU OSPR
program objectives align with the over-arching aim of the SPAD program to increase the productivity of
sponsored programs activities to enhance biomedical research and/or research training. Objective 1 promotes
biomedical research and/or research training through the provision of professional development and mentoring
for faculty in grantsmanship. Objective 2 facilitates the development of sponsored programs capacity and
administration through the development and enhancement of pre- and post-award services. The program will
focus on increasing the following short-term outcomes: increased faculty proposal writing activity, increased
faculty engagement with OSPR, increased collaborations, increased engagement with undergraduate and
graduate researchers, and increased OSPR efficiency. By focusing on these short-term outcomes, the
program should see faculty increase proposal submissions, students increase research activity, OSPR
increase development of best practices, and enhanced management of pre- and post-award activities. These
intermediate outcomes should, in the long-term, lead to increased faculty and student grant activity to include
publications, presentations, and awards and improved grants management. Finally, an increase in faculty
research activity, an increase in overall student research activity leading to a rise in the number of students
who pursue biomedical research careers, and an increase in the overall productivity of sponsored programs
activity should demonstrate the impact of the program.

Public health relevance
SPAD at Midwestern State University Project Narrative Midwestern State University’s (MSU) NIH SPAD proposal addresses the critical need for increased productivity of sponsored projects administration and enhanced biomedical research and research training by addressing faculty responsibilities, institutional research culture, and MSU infrastructure.